Understanding metabolic and regulatory control of antibiotic production in filamentous actinobacteria

Project Summary
Bioactive molecules from nature are valuable templates for essential medicines. Filamentous actinobacteria are
gifted producers of such molecules and rank among the richest sources yet discovered. They produce >50% of
clinical antibiotics, plus numerous other medicines including immunotherapeutics and anticancer agents. These
organisms dedicate a substantial fraction of their genomes to gene clusters predicted to encode drug-like
compounds. Our research centers on a critical question: Why do the vast majority of actinobacterial biosynthetic
gene clusters fail to yield anticipated products? There is an urgent need for new drug scaffolds and this problem
transects multiple therapeutic areas. Gaining access to the plethora of yet-undiscovered drug-like molecules
encoded within actinobacterial genomes could broadly revolutionize medicinal discovery and development.
Coaxing actinobacteria to “turn-on” quiescent pathways is a challenge whose solution is fundamentally rooted
in microbial physiology. Building on methodology and research insights established in our prior works, we here
outline a multidisciplinary program that investigates two families of antibiotic molecules as models to reveal new
mechanisms controlling production phenotypes. These molecules, polycyclic tetramate macrolactams and
piperazyl-peptides, are broadly distributed among filamentous actinomycetes. They are largely chemically and
biosynthetically distinct but share a common link via ornithine metabolism. Goal 1) Our prior works establish
small nucleotide changes in transcriptional promoters can “tune” antibiotic production. How do these promoter
polymorphisms exert their control? How can this knowledge be applied to override poor production traits? Goal
2) Certain piperazyl pathways respond positively to ornithine and related pathway intermediates. This suggests
a mechanism of metabolic control. We ask: Because both types of antibiotics we study require ornithine
precursors, might cellular ornithine status constitute an important regulatory component that could empower
discovery strategies for both? Goal 3) We recently established a positive relationship between cellular growth
on solid surfaces and polycyclic tetramate macrolactam production in certain strains. We hypothesize this
intriguing relationship may extend to other antibiotic production pathways as well. We ask: How do
actinobacterial surface interactions modulate bioactive molecule production, and might answering this deliver
novel insights for broad-scale biosynthetic activation?

Public health relevance
Project Narrative Filamentous actinobacteria are prodigious producers of bioactive molecules and essential medicines. The genomes of these organisms are highly enriched with gene clusters predicted to encode many more drug-like compounds, but accessing the full biosynthetic potential of these organisms has been challenging. Our research seeks to identify and characterize new metabolic and regulatory mechanisms that control biosynthetic gene clusters, empowering genomics-guided drug discovery and thus increasing human health.